CIRI Oncology Research Alliance

PROJECT SUMMARY/ABSTRACT
The CommonSpirit Health Research Institute (CSHRI) Oncology Research Alliance (CORA) seeks to continue
to support and expand a community-based cancer research network, made up of community hospitals and
cancer centers and incorporate best practices in enrolling patients to National Cancer Institute (NCI)-
sponsored cancer control, prevention, and care delivery clinical trials and other human subjects’ studies. The
specific aims are: to increase enrollment in cancer control, prevention and care delivery clinical trials by
providing access to a wide portfolio of high quality research studies that meet the needs of CORA’s various
populations, annually accruing 10% of new cancer cases within the populations served by the network; and
identify, design and implement Cancer Care Delivery Research (CCDR) that leads to improved models of care
and translates to high-quality, value-based services throughout the oncology continuum. Applying CSHRI’s
innovative, centralized and standardized organizational research model encompassing a network of
geographically diverse community cancer programs, CSHRI will continue to provide the necessary resources
for amplifying clinical trials across the country. CORA’s geographic reach and involvement with multiple distinct
primary and sub-affiliates allow it to offer a wide portfolio of trials to large, established programs as well as
small, rural sites and new regions that historically have had limited access to cancer clinical trials. Applying
best practices from CORA to all current and new primary and sub-affiliates along with increased physician
engagement will increase the number of patients screened and enrolled in clinical trials. Leveraging
CommonSpirit Health’s (CSH) unique, well-positioned standard oncology electronic health records (EHRs),
enterprise data warehouse, and analytics capabilities will continue to give CORA the depth of data and access
to information needed to expand CCDR. CSH’s EHRs at CORA sites yield accessible data across the network
that feeds into the data warehouse. CSH’s single network tumor registry database and EHR make CORA
responsive to requests for data around patterns of care. Lastly, the advanced patient navigation, survivorship,
and multidisciplinary conferences and disease site specific tumor boards already in place at all primary and
sub-affiliate sites will support this research. Expanding to additional health systems and sites, and adding new
investigators as opportunities arise will increase the number of patients that CORA can screen for enrollment in
cancer clinical trials. CORA primary and sub-affiliates’ community outreach coordinators’ and navigators’
integrated efforts will be utilized to improve cancer control and prevention, detection, care delivery, and
treatment for these populations. Continued growth of CORA’s community partner networks, translation support
and nurse navigation training at all primary and sub-affiliate sites will help eliminate barriers to care.

Public health relevance
PROJECT NARRATIVE The CommonSpirit Health Research Institute (CSHRI) Oncology Research Alliance (CORA) is a community- based research network made up of community hospitals and cancer centers that work together to recruit and enroll patients in cancer control, prevention, screening, and care delivery trials as well as quality-of-life studies. CORA also identifies, designs and implements cancer care delivery research that leads to improved models of care and translates to high quality, value-based services throughout the oncology continuum. Overall, CORA seeks to contribute to and improve cancer research and the delivery of cancer care in the community.